Regiodivergent Palladium-Catalyzed Decarboxylative Coupling of Stabilized Benzylic Nucleophiles

Project Summary
Transition metal-catalyzed carbon-carbon bond formation plays a critical role in bioactive small molecule
synthesis, both in academic and pharmaceutical industry settings. A particularly attractive tool is the
palladium-catalyzed decarboxylative allylic alkylation (DAA) reaction, which facilitates carbon-carbon bond
formation via the extrusion of a single byproduct, carbon dioxide. Despite its extensive applications in the
preparation of medicinally relevant molecules, existing strategies to engage carbon-centered nucleophiles in
DAA chemistry is limited to stabilized enolate-based and related nucleophiles whose conjugate acid pKa is
less than 25. On the other hand, the reaction of less stabilized nucleophiles (conjugate acid pKa of > 25) is
less well documented, in part due the energetic barriers associated with promoting their decarboxylation.
Additionally, the majority of Pd-catalyzed decarboxylative couplings proceed through a mechanism in which
the intermediate nucleophile and allylpalladium species react to predominantly deliver allylation products. In
contrast, reports that detail the formation of the regioisomeric cyclopropanation product remain relatively
scarce. To address these limitations, we have devised a new approach that relies on the use of aromatic
anions as a means to stabilize and engage otherwise recalcitrant nucleophiles in decarboxylative coupling
chemistry. Specifically, we recently demonstrated that allyl ester-substituted phthalides undergo efficient
allylation in the presence of a Pd/Xantphos catalyst, delivering a variety of functionalized phthalides in
excellent yield. Interestingly, when Xantphos is replaced with the bisamino ligand tetramethylethylenediamine
(TMEDA), a cyclopropanated phthalide is isolated in high regioselectivity. The goal of Aim 1 is to significantly
expand on these preliminary findings by applying our optimal Pd/Xantphos DAA catalyst to access a variety
of biologically relevant motifs, including functionalized isoindolinone and fluorene derivatives. Alternatively,
Aim 2 seeks to exploit the reactivity Pd/TMEDA-based catalyst to develop a general decarboxylative
cyclopropanation of phthalide-based nucleophiles. Finally, the goal of Aim 3 is to elucidate the mechanistic
basis of the regioselectivity for allylation versus cyclopropanation chemistry via structural, kinetic, and
computational studies. The successful implementation of this proposal constitutes a significant expansion of
the breadth of Pd-catalyzed decarboxylative coupling, establishing access to a wider family of bioactive
structural motifs while engaging undergraduates in impactful yet practical research endeavors.

Public health relevance
Project Narrative The development of chemical tools to access bioactive small molecules is a central tenet of organic chemistry, enabling the study and application of pharmaceuticals that directly impact human health. The goal of the proposed research lies in the development of new catalytic tools to prepare an array of bioactive compounds. The success of these studies will result in the discovery of new pharmacophores that can be constructed in an atom-economical fashion.